Administration Core

Abstract – Administration Core
The overall goal of the Center for Biomolecular Structure (CBMS) at National Synchrotron Light Source II (NSLS-
II) is to provide access to a broad range of state-of-the-art synchrotron capabilities at the NSLS-II. The proposed
synchrotron center will be supported by both the National Institute of General Medical Sciences/National
Institutes of Health (NIGMS/NIH) and the Department of Energy Office of Biological and Environmental
Research (DOE BER).
The CBMS team will administer the Center to allow for safe, responsive use by the research community, we will
monitor use and develop the capabilities as appropriate to need. We will provide review-based access, training,
and technical assistance to assure success of research programs that use this remarkable set of synchrotron
resources.
To pursue our support mission, we plan to make the best use of NSLS-II capabilities by employing multiple
mature synchrotron technologies. We will support macromolecular crystallography (MX) at our micro-focusing
beamlines through on-site visits, automatic data collection processes, and remote beamline access. For X-ray
scattering we will support, static and online HPLC-backed small-angle scattering (SAXS). In addition, we will
continue to extend the impact of the scanning-beam method for SAXS tomography and to support the use of low-
energy x-ray scattering studies. We are now able to propose the addition of synchrotron x-ray footprinting (XF),
as a mature complementary technique, to the existing resources available within CBMS. We will continue to
develop all these tools, driven by the needs of the biological and environmental-science communities.